Biostatistics and Bioinformatics Shared Resource (BBSR)

BIOSTATISTICS & BIOINFORMATICS: ABSTRACT
The goal of the Biostatistics & Bioinformatics Shared Resource (BBSR) is to ensure excellent and timely
collaborative support in a cost-effective manner for all Research Programs of the University of Arizona Cancer
Center (UACC). In 2020, bioinformatics services were combined with the existing Biostatistics Shared
Resource to provide UACC investigators with one cohesive team to achieve a high level of statistical rigor and
innovation in their research. This integration was a result of an external ad hoc review of Shared Resources
conducted in 2020. This change is critical in an era when many animal studies and clinical trials involve the
collection of ‘omics data. Under this new structure, BBSR provides efficient design, accurate data
management, and customized data analyses and interpretation, as well as statistical and bioinformatics
innovations, to ensure UACC investigators achieve their scientific goals. This support is facilitated by the long-
term coordination of BBSR personnel across all three UACC Research Programs and campus-wide data
science initiatives. BBSR faculty and staff are collaboratively involved in the conception, design,
implementation, analysis, and reporting of laboratory, genomic, clinical, and population-based research
conducted within the UACC. BBSR provides the following services: (1) integrated biostatistical and
bioinformatics analysis planning for grant applications; (2) biostatistical and bioinformatics analysis of user-
generated and publicly available data; (3) monitoring of clinical study progress; (4) data and software
management; (5) clinical protocol development including sample size justification; (6) statistical review of
UACC protocols through service on the Scientific Review Committee (SRC); (7) monitoring study safety and
data integrity through service on the Data and Safety Monitoring Board; and (8) education and training for
clinical fellows, students, and UACC Members. In CY20, BBSR served 35 UACC Members, provided statistical
protocol development support for 10 UACC investigator-initiated trials, and provided statistical reviews for 63
SRC protocols. Over the course of the project period, BBSR has supported 97 publications by UACC Members
and 203 peer-reviewed funding applications.